Synthetic Strategies to Restore the Efficacy of Venetoclax in Acute Myeloid Leukemia

Project Summary. Increased cell survival due to inhibited apoptosis through overexpression of anti-apoptotic
BCL-2 family proteins is a hallmark of cancer that is a prominent mechanism in acute myeloid leukemia (AML),
one of the deadliest human cancers. Although the FDA recently approved several new drugs for treatment of
AML, these target only specific subsets of AML cases, and provide only short responses. Indeed, treatment
with the BCL-2 inhibitor venetoclax (VEN), an emerging standard-of-care drug for AML, partnered with other
drugs has resulted in only ~19% responses and only ~17 months median survival due to the onset of
resistance. There is a clear and urgent need for more effective pharmacotherapies for AML.
The BCL-2 family of proteins regulates the intrinsic apoptosis pathway, and includes both anti-apoptotic
and pro-apoptotic members. The anti-apoptotic proteins, BCL-2, BCL-xL, MCL-1, BCL-w and A1, seize their
pro-apoptotic partner proteins, such as BAK and BAX, via their amphipathic -helical BH3 domains. VEN is a
small-molecule BH3 mimetic that is prescribed in chronic lymphocytic leukemia as well as AML, and potentially
other BCL-2 dependent cancers, but its efficacy is abrogated by the development of resistance. The best
characterized mechanisms of VEN resistance are upregulated expression of MCL-1 and the development of
BCL-2 mutants that are no longer effectively recognized by VEN; currently, there are no clinical solutions to
either of these resistance mechanisms.
VEN recently demonstrated synergy in vitro and in vivo with a range of clinical drugs and advanced drug
candidates that target a variety of additional proteins, with a unifying theme that the partner drug either leads to
downregulation/inhibition of MCL-1 and/or upregulation of pro-apoptotic BCL-2 proteins. Since the discovery of
new, highly-targeted AML drugs de novo is time- and money-intensive with no guarantees of success, we
propose to utilize a polypharmacology approach, in which single drugs will be rationally designed to hit multiple
targets relevant in AML, by leveraging FDA-approved drugs and those in clinical trials. Polypharmacology
offers potential advantages over combination therapy, such as increased therapeutic windows and increased
patient compliance. Accordingly, the solvent-exposed tetrahydropyran motif of VEN will be replaced with co-
drugs that have demonstrated synergy with VEN. Similarly, we will exploit the exciting area of proteolysis
targeting chimera (PROTAC) research by grafting E3 ubiquitin ligase recognition motifs onto VEN, promoting
the recruitment of BCL-2 to the proteasome for degradation. This PROTAC strategy can be effective even with
weaker binding ligands and thus may address the issue of resistance mutations in the BCL-2 protein. Lead
compounds that potently inhibit the proliferation of VEN-sensitive and VEN-resistant AML cell lines in vitro will
be evaluated in human AML xenografts. By the end of the funding period, we envisage discovering at least one
VEN-based chimeric compound suitable for further preclinical evaluation in AML (and other cancers).

Public health relevance
Public Health Relevance Statement Overexpression of anti-apoptotic BCL-2 family proteins and consequent reduction of programmed cell death are hallmarks of acute myeloid leukemia (AML) and multiple other cancers. Although venetoclax, a selective inhibitor of the BCL-2 protein, is becoming a standard-of-care component of AML combination chemotherapy regimens, current venetoclax-based drug regimens provide a median overall survival of only 17 months. Using a structure-based, polypharmacology drug design approach to enhance the efficacy of the venetoclax molecule, we devised and propose to evaluate several classes of venetoclax-based chimeric compounds that inhibit additional AML targets beyond BCL-2 or induce BCL-2 degradation.